Magnetic Rotational Exploratory Platform for Coronary Lesions

Cardiovascular disease (CVD) is the leading cause of mortality in the United States (US), resulting in 850,000
annual deaths, of which nearly 400,000 are associated with coronary heart disease (CHD) and myocardial
infarction (MI). By 2030, global annual deaths will exceed 20 million. More than 90 million US adults currently
live with CVD, which is associated with an annual economic burden of more than $330 billion. Together, MI
and CHD are the most expensive conditions treated in US hospitals, totaling more than $20 billion each year,
with costs expected to double by 2030. Percutaneous coronary intervention (PCI) is an effective strategy to
restore blood flow for obstructive CHD. However, while nearly 950,000 PCI procedures are performed each
year in the US, navigating tortuous vessels is challenging and enabling stent expansion within severely
calcified occlusions often fails, which are observed in ~35% and ~20% of procedures, respectively.
Rotational atherectomy (RA) and orbital atherectomy (OA) are increasingly used to debulk otherwise
untreatable lesions to enable PCI, with recent studies confirming RA and OA improve stent deliverability vs.
standard PCI without negatively affecting outcomes. To debulk severely calcified lesion, RA/OA devices
employ long (>300cm) stiff driveshafts which spin burrs/crowns at speeds up to 180,000 RPM. For both RA
and OA, the inflexible driveshaft often hinders access within tortuous vasculature. The high speeds employed
are necessary to stabilize the burr/crown about a guidewire, without which, the tip would dangerously whip.
However, the need for extreme rotational speeds greatly increases the complexity of RA/OA systems and
presents risks, which include 1) thermal injury due to driveshaft friction, 2) arterial abrasion and perforation, 3)
guidewire shattering, 4) burr/crown entrapment, and 5) embolic debris within the distal vasculature. To reduce
the risk of traumatic injury, RA and OA devices cannot be used for more than five minutes.
UNandUP has developed an interventional cardiology platform consisting of a magnetic access guidewire
and an over-the-wire rotational atherectomy catheter which are controlled using magnetic fields 100X weaker
than an MRI. The magnetic guidewire overcomes vessel tortuosity to improve lesion access, a desirable
feature for PCI in general. For the magnetic atherectomy catheter, applying magnetic forces directly to the burr
eliminates the need for 100X higher driveshaft speeds to stabilize tip rotation. Resultingly, safer and more
efficacious debulking is achieved. Further, driveshaft removal enables concurrent aspiration of embolic debris
near the burr, a feature not possible with current atherectomy devices. The team reflects leading cardiology,
RA/OA, magnetics, and robotics experts. The company maintains partnerships with leading national
laboratories and recently completed an FDA presubmission meeting and I-Corps participation. The proposal’s
aims include building a prototype magnet system, building magnetic guidewire and atherectomy devices, and
evaluating the system’s performance in tortuous cardiac phantoms and published lesion models.

Public health relevance
Cardiovascular disease is the leading cause of death, with coronary heart disease and myocardial infarction resulting in nearly 400,000 deaths in the US each year. For over 25 years, rotational and orbital atherectomy have been successful in enabling stent deliverability in severely calcified coronary lesions. However, the unique capabilities of these valuable tools have not evolved due to fundamental mechanical limitations, which include obtaining access within tortuous vasculature, adverse heating, arterial perforation, and generation of embolic debris. For this proposal, UNandUP (short for “Unmet Needs and Underserved Populations”) will demonstrate proof of concept of a novel magnetic guidewire and rotational atherectomy platform that greatly improves vascular access while providing, for the first time, concurrent aspiration of embolic debris at the burr.